Nuclear, Genomic and Molecular Regulation of Type I Interferon Transcription

DESCRIPTION (provided by applicant): Our long-term goal of this exploratory research proposal is to determine how chromosome conformation and subnuclear position affect the host response to viruses. Significance and role of large-scale nuclear processes of folding and juxtaposition of chromosomal fibers during innate immune response to viruses remain relatively unknown. However, these processes represent unexplored epigenetic targets for modulating the innate immune system for potential therapies. To understand these nuclear processes involved in anti-viral response in human cells, we will characterize the molecular mechanisms that modulate chromosomal conformation and subnuclear location of the type I interferon locus in the genome of diploid fibroblasts and lymphoblasts during viral infection. A better understanding of the regulatory mechanisms involved in the production of type I interferons is fundamental to the development of therapeutic strategies for treating viral infections and inflammatory diseases such as autoimmunity.

Public health relevance
PUBLIC HEALTH RELEVANCE: The type I interferons are critical component of the innate immune response to microbial pathogens, and they coordinate integration of innate and adaptive immune responses. Our project aims to uncover epigenetic mechanisms involving chromosome folding that mediate dynamic and precise activation of type I interferon locus in human cells. These studies will yield potential targets that can be modulated for anti-viral therapies.